SPDYE3, A Novel Cancer Testis (CT) Antigen for Glioma Immunotherapy

PROJECT SUMMARY
Gliomas are heterogeneous brain tumors with capacity for malignant propagation, and no treatment
options are curative. Our studies show that an uncharacteristic cancer testis antigen, SPDYE3 was found to
be overexpressed in all subtypes as well as low- and high-grade gliomas, and its expression is associated a
poor patient’s survival. Interestingly, SPDYE3 protein contains tandem repeat (TR) epitopes that have high
binding affinity to predominant HLA haplotypes (HLA-A*02, HLA-A*01 and HLA-B*07), which makes this
molecule a potential glioma target for TCR-based T cell therapy.
In this proposed study, we will test our hypothesis that SPDYE3 is a novel glioma tumor antigen,
which is involved in tumor progression. We anticipate translating our preclinical findings from this
proposed study into a future clinical applications for patients with various stages of gliomas.

Public health relevance
RESEARCH NARRATIVE We identified a novel cancer testis antigen, SPDYE3, and its expression is associated with poor survival for patients with in low- and high-grade gliomas. SPDYE3 protein contains tandem repeat (TR) epitopes that can be presented by predominant HLA haplotypes. These results indicate that SPDYE3 is a potential glioma antigen that can be targeted by TCR modified T cells.